Role of NOD2 Variants in Eosinophilic Esophagitis

PROJECT SUMMARY/ABSTRACT
Eosinophilic esophagitis (EoE) is a chronic allergic inflammatory esophageal disorder, exhibiting clinical
symptoms (e.g., vomiting, pain, dysphagia, food impaction) and histologic features of esophageal eosinophilia,
epithelial hyperplasia, and dilated intercellular spaces, which are indicative of impaired barrier function. EoE is
highly heritable, yet most genetic research has focused on common variants identified by genome-wide
association studies (GWAS), particularly implicating genes like calpain 14 (CAPN14) and thymic stromal
lymphopoietin (TSLP), both expressed in esophageal epithelial cells. Our research is a significant extension of
these studies, utilizing whole-exome sequencing (WES) on 1,464 patients with EoE from unrelated families, and
revealed a notable enrichment of rare genetic variants in the nucleotide-binding oligomerization domaincontaining
2 (NOD2) gene. NOD2 , a key regulator of inflammatory responses, is expressed in both eosinophils
and esophageal epithelial cells, suggesting its pivotal role in EoE pathogenesis We central hypothesize that
gain-of-function NOD2 variants contribute to esophageal epithelial dysfunction and eosinophil activation, thereby
exacerbating inflammatory responses in the type 2 immune environment. Our study comprises three specific
aims outlining an integrated set of multidisciplinary studies with the necessary statistical and experimental
support to evaluate the impact of the effects of NOD2 variants in EoE. Aim 1 investigates how NOD2 variants
impair epithelial barrier integrity, focusing on the mechanistic pathways, including NFKB signaling and reactive
oxygen species (ROS) production, that drive dysfunction in esophageal epithelial cells. We will use human
induced pluripotent stem cell [iPSC]-derived esophageal organoids with CRISPR/Cas9 genome editing to model
the effects of NOD2 variants in epithelial cells. Aim 2 explores the impact of NOD2 variants on eosinophil
activation and their interactions with epithelial cells. We hypothesize that these variants enhance eosinophil
activation and survival, further amplifying inflammation through altered intercellular signaling. By analyzing the
gene expression profiles of cocultured eosinophils and epithelial cells, we aim to clarify how NOD2 variants
contribute to EoE pathology via their influence on both cell types. Aim 3 examines the combinatory effects of
NOD2 variants with other EoE-associated genetic variants, both common and rare. This aim will help establish
whether specific combinations of genetic variants significantly increase the risk for EoE, providing insights into
genetic susceptibility and pathogenesis. Our multidisciplinary approach combines genetic, molecular, and
functional assays, utilizing advanced disease models, including iPSC-derived gastrointestinal organoids with
genome editing of iPSCs by CRISPR/Cas9. This integrative design will provide deeper insights into the genetic
mechanisms driving EoE. This research addresses a critical unmet medical need, potentially leading to more
personalized and effective treatments for EoE and related gastrointestinal conditions.

Public health relevance
PROJECT NARRATIVE Eosinophilic esophagitis (EoE) is a chronic allergic disease of the esophagus and has a complex, genetic basis. Our research using whole-exome sequencing has identified rare NOD2 variants as significant contributors to EoE, impacting both esophageal epithelial cells and eosinophils. This study aims to uncover the mechanisms by which NOD2 variants drive inflammation, with the goal of developing targeted therapies for EoE and related gastrointestinal disorders.